Instrumentation, Fabrication, and Design Core

Instrumentation and Fabrication Core Resource for Vision Sciences,
Ronald Silverman, Core Director
Summary/Abstract
The long-term goal of the Core is to provide mechanical design and fabrication support for vision research at
Columbia, especially that of investigators with RO1 grants and young investigators gathering data for their
first successful RO1s. State-of-the-art vision research is dependent upon the development of new
technology and the improvement of current technology. The Core supports a specially dedicated machine
shop and one machinist. Because the shop is in-house, and the machinist is familiar with demands of vision
research, designing new equipment is far more efficient than it would be with a University or commercial
shop. The core has four specific aims: 1)To design and build custom equipment necessary for vision
research, both systems neuroscience vision research and ophthalmic science. 2)To provide emergency
repairs and modifications for equipment currently in use for vision research. 3)To train students and
postdoctoral fellows in the most effective ways to collaborate with instrument designers. 4)To encourage
collaboration among vision research investigators, having them share ideas for new devices that might be
used in multiple laboratories. This is especially important for systems neuroscience vision research, where
similar equipment is used to answer vastly different scientific questions. Collaboration in instrument design
has often led to scientific collaboration. The Core builds the standard devices used for systems neuroscience
such as recording chambers, primate chairs and grids. Although some of these devices are available
commercially, the ones built by the Core are far more durable. Examples of custom equipment built by the
Core are cage mounted behavioral training systems to train monkeys in their home cage rather than using
rig time; a system for lifting a monkey chair to the cage opening to facilitate transfer from the cage to the
chair; a 3D ultrasound probe manipulator for blood flow studies in rat eyes. This now successful prototype
will be expanded for use in humans.